Thermosensing Mechanisms of the capsule regulator KvrA in Klebsiella pneumoniae

PROJECT SUMMARY
This project will enhance our understanding of the fundamental biology of Klebsiella pneumoniae, an important
human pathogen deemed an urgent threat by the CDC due to escalating antibiotic resistance rates. I seek to
understand how a ubiquitous and opportunistic organism, one capable of colonizing many diverse environments,
can alter its gene expression to suit its surroundings. Specifically, I am investigating the mechanism by which K.
pneumoniae senses increased temperature upon infecting a host and increases expression of its polysaccharide
coat in response.
This project builds on my experience in bacteriology as well as the importance of physiological temperature
differences in pathogenesis by focusing specifically on the known virulence regulator KvrA. KvrA regulates the
amount of capsule produced by K. pneumoniae by competing for the same binding site as H-NS, a transcriptional
silencer of capsule. Previous work has demonstrated that the translation of SlyA in Escherichia coli, homologous
to KvrA in K. pneumoniae, increases in response to temperature. Yet, the mechanism by which the environmental
signal of temperature is transduced to increase the translation of SlyA/KvrA, and the subsequent production of
capsule is unknown. I hypothesize that temperature regulates the translation of KvrA in K. pneumoniae via an
RNA thermometer (RNAT) mechanism and this sensing ability is essential for capsule expression and virulence
within the host. RNATs are secondary structures located within the 5’ untranslated region (UTR) of mRNAs that
prevent translation from occurring at ambient temperatures but “melt” to free the Shine-Dalgarno (SD) sequence
and allow translation at higher temperatures.
Through a series of parallel experiments, I will determine whether the temperature regulation of K. pneumoniae
KvrA occurs at the transcriptional or post-transcriptional level. GFP and luciferase reporter fusions will be
constructed to test the region upstream of kvrA and determine if it acts as a temperature regulator independent
of the kvrA coding sequence. In collaboration with Dr. Adrianus (“Jacco”) Boon, an expert in RNA structural
biology at Washington University in St. Louis, I will characterize the secondary structure of the 5’ UTR of kvrA at
both 37°C and 20°C using SHAPE-MaP. Alternative methods are available to investigate other non-RNAT
thermoregulatory mechanisms of KvrA. A well-established murine model of pneumonia will be leveraged to
evaluate the significance of this KvrA thermoregulatory mechanism in vivo. I will compare the virulence of strains
with stabilizing mutations in the kvrA 5’ UTR predicted to resist melting at 37°C to those with a wild-type kvrA 5’
UTR. I will also evaluate the role of krvA in strains lacking H-NS, thus determining if KvrA’s thermoregulatory
effects on capsule are independent of H-NS. With the rise of antibiotic resistance, it is critical to find alternative
methods for treating and preventing K. pneumoniae infection. This proposed work will define a critical mechanism
of K. pneumoniae environmental sensing that may be amenable for therapeutic targeting.

Public health relevance
PROJECT NARRATIVE Klebsiella pneumoniae is a Gram-negative bacterium that is both a soil microbe and an important global pathogen. The translation of the protein KvrA, which regulates the expression of capsule, the most important virulence factor in K. pneumoniae, is hypothesized to be temperature-dependent. In this proposal, I will elucidate the mechanism by which K. pneumoniae senses increased temperature inside a host and upregulates capsule via increased translation of KvrA, which I hypothesize occurs via an RNA thermometer.